Testing Effects of Swim Instruction on Autistic Children's Swimming and Water Safety Skills

PROJECT SUMMARY/ABSTRACT
Autistic Children are at 160 times greater risk of drowning than the general pediatric population. Though swim
instruction is recommended as a drowning prevention strategy, there is extremely limited research evaluating
swim instruction for autistic children and no comparative trials. We developed Sensory Enhanced Aquatics
(SEA), a swimming and water-safety program specifically to accommodate autistic children’s unique
challenges and learning needs. Program evaluation data showed SEA improved children’s swim skills, with
74% improving at least one swim level (n=40) and 100% of parents feeling safer with their child around water.
Thus, we propose to conduct a single blind, randomized controlled pilot trial to test the differential effects of an
eight-week (16 lesson) SEA intervention and standard swim lessons on attainment of swimming and water-
safety skills of autistic children. We will enroll 50 autistic children aged 5-9 years who will be randomized 1:1 by
minimization to either the SEA intervention or standard swim lessons to minimize imbalanced group allocation
by autism severity and baseline swim skill. Aim 1 will compare the effects of SEA to standard swimming
lessons on swimming and water safety skills of autistic children with a swim test based on Red Cross water-
competency guidelines. Aim 2 will assess which participant characteristics (e.g., age, motor ability, autism
severity) are associated with the highest post-intervention swim skills and water safety across both groups to
inform who benefits most from swim instruction. Child sex and co-occurring motor impairment will be
considered as potential covariates. Data will be collected before swim lessons and after 8 weeks of SEA or
standard lessons. We hypothesize children in both groups will demonstrate improvement in swimming and
water safety skills with greater improvements in the SEA group; autism severity and motor ability will have the
greatest associations with swim skill in both groups. Our exploratory aim will employ post-intervention semi-
structured interviews to explore child, parent, and instructor perspectives about instructional methods most
effective for developing swimming and water-safety among autistic children. The information obtained from this
study will improve our understanding of the best strategies for swim instruction for autistic children and support
our long-term goal to make SEA scalable on the national level to prevent drowning of autistic children.

Public health relevance
PROJECT NARRATIVE Effective programs for swimming and water-safety instruction for autistic children are not currently available and tremendous variability among types and techniques of swim instruction exists. This project will compare the effects of a specialized swimming and water-safety program for autistic children (Sensory Enhanced Aquatics-SEA) to standard swimming lessons, examine characteristics of instruction associated with skill attainment, and explore child, parent, and instructor perspectives about instructional methods most effective for developing swimming and water-safety among autistic children. If the project is successful, it will increase knowledge of best practice swim instruction for autistic children to potentially reduce the high risk of drowning in this population.